CSHL 2024 Conference on the PARP Family & ADP-Ribosylation

Cold Spring Harbor Laboratory Conference on
The PARP Family and ADP-ribosylation
April 3 – 6, 2024
ABSTRACT
This proposal seeks support for a meeting on “The PARP Family and ADP-ribosylation” to be held at
Cold Spring Harbor Laboratory (CSHL) on April 3 – 6, 2024. ADP-ribosylation is a posttranslational
modification (PTM) of proteins, RNA, and DNA catalyzed by a family of enzymes known as PARPs (17 in
humans). PARPs use nicotinamide adenine dinucleotide (NAD+) to catalyze ADP-ribosylation. A curious, and
critically important, feature of PARPs is their ability to catalyze two forms of ADP-ribosylation: (i) mono-ADP-
ribosylation (MARylation), which involves the transfer of a single unit of ADP-ribose, and (ii) poly-ADP-
ribosylation (PARylation), which involves the transfer of multiple units of ADP-ribose. Similar to other PTMs,
ADP-ribosylation is reversible. Indeed, enzymes that reverse PARylation (e.g., PARG, TARG1) and
MARylation (e.g., MacroD2, ARH3) have been identified. In the early days of the PARP field, the focus was
solely on PARP1, which revealed critical roles for PARP1 in the DNA damage response (DDR). These studies
ultimately lead to the validation of PARP1 as a therapeutic target for the treatment of DDR defective cancers.
To date, there are four FDA-approved PARP1 inhibitors for a subset of breast and ovarian cancers and several
more in the pipeline. In several cases, PARP1 inhibitor treatment resulted in distant disease-free survival,
demonstrating their tremendous clinical success and how the field has translated fundamental discoveries into
therapeutics. And we are just getting started. Recent studies have expanded our understanding, not only of the
role of PARP1 outside of DNA repair but also of the roles of lesser-understood PARP family members in
diverse cellular processes, including post-transcriptional and post-translational regulation, protein degradation,
and innate immune signaling. These studies have been advanced with the advent of new technological
developments in the field, especially in chemical biology, structural biology, and mass spectrometry. Several
PARPs beyond PARP1 have emerged as therapeutic targets not only for cancer but also for inflammation and
infectious diseases. Indeed, inhibitors of PARP7 and PARP14 are currently in clinical development. These are
indeed exciting times for the PARP and ADP-ribosylation field, both in terms of the expansion into new areas of
physiology and disease and novel therapeutic development.
This meeting will assemble leaders in the field, together with junior faculty, postdoctoral fellows, and
graduate students, to present, review, and discuss current research on PARPs and ADP-ribosylation. Critically,
this unique and timely meeting will bring together scientists from both academia and industry working in
various biology and chemistry disciplines, enhancing scientific diversity and providing a good balance between
fundamental and translational research. Each session will be chaired by two leading scientists in the field, both
in academia and industry. Longer format, oral presentations will be given by distinguished scientists as well as
rising stars in the field. Shorter format, oral presentations will be given by scientists selected from the
abstracts; these will include graduate students, postdoctoral fellows, and junior faculty, aiming for maximal
inclusion of young investigators, and importantly scientists from groups historically excluded and
underrepresented in the biomedical sciences. We expect about 175 people to attend, with the vast majority
presenting a poster or talk. Overall, this meeting - the premier meeting in the PARP field - will support the
robust exchange of ideas and promote collaborations.

Public health relevance
The PARP Family and ADP-ribosylation Project Narrative ADP-ribosylation is unique among post-translational modifications because it contains both nucleic acid and sugar features. ADP-ribosylation is catalyzed by a family of enzymes (17 in humans) known as PARPs. PARP- mediated ADP-ribosylation has widespread roles in fundamental cellular processes: from DNA repair and transcriptional regulation to the regulation of protein stability and mRNA translational regulation. PARPs are clinically relevant, and small molecule inhibitors are sought-after drug targets. Currently, there are several FDA-approved inhibitors of the founding member PARP1, which have demonstrated tremendous clinical success in the treatment of certain forms of ovarian and breast cancer. In recent years other, lesser-studied PARP family members (e.g. PARP7 and PARP14) as well as enzymes that recognize and reverse ADP- ribosylation, have emerged as exciting new therapeutic targets for cancer and inflammatory diseases. Transformative new tools developed in the last couple of years have revealed new functions for PARPs and ADP-ribosylation, and have expanded the field in exciting new directions.